Addressing Gaps in Language Access Services through a Patient-Centered Decision-Support Tool

Project Summary
Despite a growing need for language access in healthcare settings, the absence of effective patient-provider communication negatively impacts patient outcomes. This project will develop and pilot a technology-enabled platform, as a comprehensive tool that will allow providers to get information about available language services for a particular patient, and implement these services into care plans through a point-of-care tool integrated with the Electronic Medical Record. In addition, a Decision-Support Dashboard will support administrators in managing their language services assets, setting parameters that govern personalized language support plans for patients. As part of the product development, we will implement a beta version at inpatient hospital systems following a multi-step implementation plan. We will then evaluate the effect of the product on the metrics of overarching areas of impact: administration, patient experience and satisfaction, and clinical operations. Particular attention will be paid to the user adoption process in order to ready the system for commercial rollout.

Public health relevance
Project Narrative Despite policies that mandate language access in healthcare settings, the growing population of individuals with limited English proficiency (LEP) in the United States encounters language barriers in the medical system that negatively impact patient outcomes and cause significant burdens on the health systems that struggle to deliver equitable care. This project will develop and pilot a technology-enabled platform that will allow providers to quickly get information about the available language services for a particular patient, seamlessly implement these services into their care plan, and easily complete the necessary administrative steps associated with providing comprehensive language services.